Investigating the function of a ciliary protein in neural development

PROJECT SUMMARY/ABSTRACT
Synapses serve as vital intercellular connections facilitating rapid and accurate transmission of information
between neurons. Successful nervous system development is dependent on proper synapse formation, an
intricate and highly coordinated process regulated by complex cellular and molecular mechanisms. Elucidating
the mechanistic underpinnings of synapse formation holds significant promise in advancing our understanding
of neurodevelopmental and neurodegenerative disorders. The purpose of this proposal is to uncover novel
molecular mechanisms involved in synapse formation, particularly as it pertains to neurological disorders. Using
genetics, super resolution microscopy, and in-vivo unbiased proteomics, I will explore novel mechanisms that
regulate synapse formation in the nervous system. My doctoral training will provide the essential foundations for
me to become a successful independent investigator. Our preliminary studies have led to investigating a ciliary
protein with poorly understood function in cilia. We have found this ciliary protein is the most prominent hit in
affinity-purification proteomics data with RPM-1. RPM-1 is a known regulator of nervous system development
and the human ortholog MYCBP2 is involved in a neurodevelopmental disorder. Using C. elegans as my model
organism, research in Aim 1 will investigate the function of this ciliary protein in GABAergic neurons and elucidate
its relationship with the RPM-1 ubiquitin ligase and signaling hub. I hypothesize that this ciliary protein has a
non-ciliary function in synapse formation of GABAergic motor neurons and is involved in the RPM-1 signaling
network. Studies in Aim 2 will focus examine the functional role of this protein in ciliated neurons for the first time
using the C. elegans model organism. I will investigate how this player shapes ciliated neuron development by
using genetics and neuron-specific transgenic approaches. Completion of these studies will provide me with the
necessary knowledge and skillset to further investigate genetic regulatory mechanisms that shape
neurodevelopment.

Public health relevance
PROJECT NARRATIVE Synaptic dysfunction results in a diverse range of neurological disorders, occurring both during early neurodevelopmental stages and later in life during degenerative processes. Understanding the genetic mechanisms that regulate proper synapse formation in the nervous system is critical for identifying potential therapeutic interventions for neurological disorders. The work in this proposal will use in-vivo experimental techniques such as CRISPR editing and engineering, genetics, and biochemistry, providing me with a strong foundation towards becoming an independent investigator.